Gamma delta T cells promote inflammation in aviremic HIV infection and normal aging

ABSTRACT
Even with successful viral control, HIV-infected individuals exhibit co-morbidities associated with older age,
including osteoporosis, stroke, dementia, and cancer. In aviremic HIV+ individuals and the general geriatric
population, age-associated diseases and mortality correlate with plasma markers of inflammation and intestinal
permeability. The gut is a major reservoir of latently HIV-infected cells, and HIV enteropathy, defined as
pathologic processes in the small intestine and colon, is a hallmark of HIV infection. Our preliminary data
implicate gamma delta T cells as an inflammatory driver in ART-suppressed HIV infection and with normal
aging. gamma delta T cells are a non-conventional T cell lineage that comprise ≤10% of circulating T cells yet are found in
considerably higher proportions in the epithelium of the intestine. Also, there is evidence that this unique T cell
population regulates intestinal barrier function during normal conditions, and that gamma delta T pro-inflammatory activity
causes damage at epithelial sites and to epithelial barriers. Therefore, we hypothesize that with virally
suppressed HIV infection and with normal aging, gastrointestinal gamma delta T cells are stimulated via directly harboring
HIV and/or exposure to inflammatory factors and this aberrant activation leads to breakdown of tight junctions of
the intestinal epithelial barrier, causing increased release of microbial products and inflammatory gamma delta T cells into
the circulation. Further, we predict that aged gamma delta T cells exhibit functional profiles skewed towards inflammatory
cytokines/cytotoxicity in response to either direct HIV infection and/or stimulatory factors. In this application, we
propose to test these hypotheses using advanced and innovative approaches, including 25-color flow cytometry,
31-color imaging mass cytometry of recto-sigmoid biopsies, 19- and 33-plex analyses of plasma and cell culture
supernatants, respectively, and multiple algorithms for multivariate analysis of collected datasets. Our
bioinformatic data analysis plan will enable identifying novel gamma delta T cell subsets and parsing the differential impacts
of age with and without HIV infection. In Aim 1 we will perform a cross-sectional study of our HIV and Aging
cohort to determine the links between circulating gamma delta T cell subsets, plasma inflammatory and intestinal
permeability markers, and intestinal architecture and cellular composition. In Aim 2 we will determine the
temporal links between gamma delta T cell subsets, plasma markers, and the onset and/or progression of geriatric
outcomes via a longitudinal study of older subjects with and without ART-suppressed HIV. In Aim 3, we will
perform in vitro assays to determine how age and HIV infection impact gamma delta T cell functions, including the capacity
to breakdown intestinal epithelial cell monolayers. We predict that our proposed experiments will identify the
biological mechanisms that drive the increased systemic inflammation and age-associated comorbidities in both
aviremic HIV+ individuals and the general geriatric population; such insight could lead to the development of
novel therapeutics to reduce ‘inflamm-aging’-associated diseases and deaths.

Public health relevance
PROJECT NARRATIVE In individuals with HIV infection, chronic inflammation is present even with undetectable viral loads, and such persons often present with co-morbidities associated with older age, including bone loss, cancers, stroke, cardiovascular disease, and dementia. In this application, we propose to test the hypothesis that gamma delta T cells, a unique ‘innate-like’ T cell subset, exhibit hyper-inflammatory activity in the gastrointestinal tract of aviremic HIV+ individuals and uninfected older subjects, and this aberrant activation directly causes increased permeability of intestinal epithelium, leading to movement of GI microbial products and inflammatory gamma delta T cells into the circulation, which spurs and propagates systemic inflammation. Identification of the mechanisms driving increased intestinal permeability with aviremic HIV infection and normal aging is critical to develop novel therapeutic strategies to abrogate and/or prevent age-associated co-morbidities.